Phase resolved ARF optical coherence elastography for intravascular imaging

PROJECT SUMMARY
Cardiovascular disease is responsible for 1 in 4 deaths, or 650,000 Americans, every year. It is the
leading cause of death in the United States. Ruptured atherosclerotic plaques are the main cause of acute
coronary events, and it is of lethal consequence. Clinically, early detection of the latent vulnerability of plaques
is the first line of defense against such deadly circumstances, and it relies on visualizing both tissue structural
and biomechanical properties. Accurate characterization of a plaque lesion can facilitate better treatment
management by further our understanding in the disease progression.
The long-term objective of this proposal is to develop a multimodal intravascular imaging system that
combines optical coherence tomography (OCT), ultrasound imaging (US), and shear-wave-based optical
coherence elastography (OCESW) for studying and characterizing plaque vulnerability. The proposed system,
IVOCT-US-OCESW, is built upon the ARF-OCE technology developed in the preceding proposal, with several
significant technical advancements that will further facilitate its clinical translation. The proposed IVOCT-US-
OCESW system unifies the high spatial resolution and extended penetration depth of the 1.7-µm OCT, the broad
imaging depth of US, and the enhanced biomechanical contrast of OCESW. It will provide physicians a powerful
clinical instrument for studying, diagnosing, and managing vulnerable plaques. The multimodal probe only
requires a single disposable guide wire and catheter, thereby reducing the costs, procedure length, associated
risks, and X-ray exposure. Our specific aims are to: 1) Design and construct a multimodal IVOCT-US-OCESW
imaging probe; 2) Develop the IVOCT-US-OCESW system featuring a 4-MHz, 1.7-µm laser; 3) Establish a
scanning protocol and algorithms for biomechanical property quantification; 4) Demonstrate the efficacy of the
proposed system in normal and diseased animal models.
We expect the development of the proposed high-speed, high-penetration-depth, and high-sensitivity
IVOCT-US-OCESW system and probe to have significant impact to both basic science and clinical understanding
of plaque pathogenesis. This will enhance the clinicians’ ability to identify vulnerable lesions, tailor interventional
therapy, and monitor disease progression. More importantly, it will be a powerful tool that provides a quantitative
means to benchmark and evaluate new medical devices and therapies.

Public health relevance
PROJECT NARRATIVE As the leading cause of death in the United States, cardiovascular disease is responsible for 1 in 4 deaths, or 650,000 people, every year. We propose to develop a multimodal intravascular imaging system that combines high resolution of optical coherence tomography, deep tissue penetration of ultrasound, and biomechanical contrast of optical coherence elastography. The proposed imaging technology will enhance the clinicians’ ability to identify vulnerable lesions, tailor interventional therapy, and monitor disease progression. It will be a powerful tool that provides a quantitative means to benchmark and evaluate new medical devices and therapies.